Advances in Cardiovascular Science: From Discovery to Translation

ABSTRACT
This proposal requests NHLBI support for the 2024 Scientific Sessions meeting presented by the Council on
Basic Cardiovascular Sciences (BCVS) of the American Heart Association (AHA). This meeting has become the
“go to” meeting for basic and translational cardiovascular sciences by providing opportunities for established and
emerging investigators to present their work and receive constructive feedback. The meeting in 2024 represents
the 19th consecutive annual conference. Funding for BCVS Scientific Sessions from National Heart, Lung and
Blood Institute (NHLBI) has been secured for 15 of the last 17 years. The BCVS summer conference is entitled
“Advances in Cardiovascular Science: From Discovery to Translation”. In 2023, our in-person conference
was a rousing success with more than 1,000 investigators from around the world. We plan to again hold an in-
person meeting in 2024 to help facilitate the careers and networking opportunities for young investigators, and
support collaborations. The meeting is scheduled for July 22-July 25, 2024 and will begin on a Monday and run
through Thursday. The conference will highlight the newest basic and translational cardiovascular research with
implications for cardiovascular health and disease. There will be approximately 14 scheduled state-of-the-art
sessions that include a mix of established and emerging investigators. The 2024 BCVS keynote address will be
given by Dr. E. Dale Abel, the William S. Adams Distinguished Professor of Medicine and Chair and Executive
Medical Director of the Department of Medicine, David Geffen UCLA School of Medicine. There are specific
sessions for early career scientists, including two early career sessions, an Early Career Keynote Lecture, and
the Outstanding Early Career Investigator Award Competition. We will host special sessions for networking
including interactions with journal editors and staff. We will also include the Women in Science Breakfast to
support female scientists. At every step, we will focus on diversity and inclusivity to promote the very best
cardiovascular science. This R13 proposal is designed to provide support to young investigators to enable their
participation in the meeting as presenters either in oral or poster format. The primary organizers are Drs.
Sumanth Prabhu and Farah Sheikh. The Program Committee (11 members) includes the past program co- chair
and a diverse leadership from across the US drawn from the many disciplines encompassed by BCVS. The AHA
will continue to provide its outstanding administrative support with dedicated staff for the logistics of the
conference. We fully anticipate that this team will coordinate an exceptional 2023 BCVS conference.

Public health relevance
NARRATIVE This award will support the 2024 summer meeting for the Basic Cardiovascular Sciences Council of the American Heart Association. The purpose of this meeting is to allow scientists to exchange information on the basic and translational mechanisms of heart disease to help stimulate collaborations and new investigation. We also promote the careers of emerging scientists and trainees.